The Cortical Dynamics of Motor Activity During Speech Production

Speech is critical for human communication, but the cortical control of the fundamental movements of speech production is not clearly understood. Current knowledge primarily stems from functional imaging and lesion studies, which lack the ability to observe rapid changes in activity. Advances in electrocorticography (ECoG) now enable investigation of rapid changes over multiple cortical regions. Early ECoG studies have found ventral motor cortex (M1) activity broadly related to large vocal pitch change and loosely correlated with production of speech sounds, or phonemes. I have demonstrated that even single instances of phonemes can be identified during word production from patterns in activity in M1. However, motor control studies show M1 activity primarily represents movements. Correspondingly, the movements of speech, such as those of the laryngeal musculature involved in vocal pitch, are well understood. Similarly, phonology literature suggests the basic units of speech production are simple articulator movements, or gestures, such as tongue tip closure. Despite strong evidence for movement representation in M1, speech movements have yet to be been investigated with ECoG. The objective of this proposal is to elucidate how the motor cortices control speech movements of articulators and vocal pitch. The research aims of this proposal are to determine the cortical representation of articulatory gestures and vocal pitch during speech and non-speech movements. I will decode high-gamma activity (70-200 Hz) of M1, premotor cortex (PM) and inferior frontal gyrus (IFG) to estimate representation of these movements. Decoding accuracy will quantify the extent to which gestures are represented in each cortical area during speech and non-speech movements. Preliminary results reveal distinct cortical signatures in M1 related to gesture production. Completion of these goals will result in a model of cortical representation of speech movements. This work will enable substantiation of neurophysiological theories, lead to practical applications for patients, and enable investigations of motor activity during higher- order processes of speech. Moreover, we enable comparison of speech to other motor control processes. Results will improve understanding of the cortical representation of the larynx, which remains poorly understood in human physiology research.

Public health relevance
This study examines cortical activity of motor areas during speech production, with the goal of identifying the cortical representation of articulatory movements and vocal pitch. This research will address fundamental questions about speech motor control during production and phonation, which will enable evaluation of neurophysiological theories and lead to practical applications for patients.